Novel first-in-class Therapeutics for Rheumatoid Arthritis

Novel first-in-class Therapeutics for Rheumatoid Arthritis
Biotherapeutics Inc (BTI) is an emerging biotech company that synergistically combines the power of advanced
computational modeling with translational experimentation to accelerate the development of novel products for
precision medicine and health. This SBIR application will advance the development of a novel oral first-in-class
therapeutic for rheumatoid arthritis (RA).
Our Product: We have identified a family of small-molecule therapeutics that bind and activate a novel
therapeutic target with immunological and metabolic functions. The goal of this project is to develop our lead
binding-agonist, as an oral, first-in-class therapeutic for RA.
Background: RA is a disabling chronic inflammatory disorder affecting 1.5 million patients in the U.S., with a
total annual societal cost exceeding $39 billion. Limited therapeutic efficacy and abundant safety concerns,
among the classes of current therapeutics in the market, result in an unmet clinical need for the development of
safer and more effective RA therapeutics with novel mechanisms of action. Our novel drug candidate binds and
activates a newly identified pathway with therapeutic properties that ameliorates disease severity and
inflammation in animal models of RA, suppressing inflammatory responses in immune cells plus modulating
fibroblast-like synoviocytes (FLS) activation. This SBIR Phase I project will develop our lead-binding agonist
for RA, validate its therapeutic efficacy and safety and characterize its mechanisms on FLS activation during
RA. The Specific Aims are to:
AIM 1. Conduct pharmacokinetic (PK) and safety studies to determine oral bioavailability, tissue distribution
and half-life as well as a 14-day repeat-dose toxicity in rats.
AIM 2. Characterize the effects of our lead compound on human fibroblast-like synoviocyte metabolism
and activation through analysis of metabolic profile and assessment of key metabolic enzyme activity.
AIM 3. Compare the therapeutic efficacy of the lead compound to current approved RA therapeutics in
two rat models by clinical scores, joint histopathology, inflammatory markers, and flow cytometric analysis.
Expected Outcomes: Validation of our lead compound as a novel therapeutic candidate for the treatment of RA
that: i) inhibits the increased glycolytic usage in activated FLS from RA patients, ii) ameliorates synovial
inflammation in vivo; and iii) has a benign safety profile with NOAEL ≥ 1,000 mg/kg.
SBIR Phase II will validate the therapeutic efficacy of this novel drug candidate in chronic models of RA, perform
ADME and off-target assays and advance our novel drug candidate to IND-enabling studies.
Commercial Application: This project will develop a new drug program of small molecule therapeutics that
exert anti-inflammatory functions through modulation of multi-pronged mechanisms of action. This new drug
development program could disrupt the RA expanding market of $25 billion.

Public health relevance
Public Health Relevance Rheumatoid Arthritis (RA) is a chronic disabling condition that afflicts over 1.5 million of Americans and approximately 1% of the population worldwide, resulting in total societal annual expenses of $39 billion in the U.S. This SBIR Phase I application has the potential to develop a novel class of potent oral drug candidates for RA that exert their therapeutic actions through immunological and bioenergetic mechanisms and advance them along the FDA regulatory pipeline into IND, clinical testing and commercialization. This project will lay the groundwork for developing our lead drug candidate as an oral first-in-class small molecule therapeutic that regulates synoviocyte activation and exert anti-inflammatory functions that provide protection from immune infiltration, cartilage destruction and disease during RA.